Investigating the Functional Impact of AD Risk Genes on Neuro-Vascular Interactions

PROJECT SUMMARY/ABSTRACT
Cerebrovascular pathology is present throughout stages of Alzheimer’s Disease and is correlated with cognitive
changes. There is strong evidence that vascular dysfunction is a significant driver of neuropathology. Our long-
term objective is to understand the function of Alzheimer’s Disease-associated risk genes in vascular cells, their
contribution to the development of cerebrovascular pathology and the opportunities to use this information in
therapeutic development. There are over 27 Alzheimer’s Disease-associated risk (AD-risk) loci encompassing
numerous genetic variants in non-coding and coding regions and hundreds of linked genes. Our overarching
hypothesis is that a subset of AD-risk genes impairs vascular function, causing release of inflammatory factors,
blood brain barrier (BBB) impairment, and reduced perfusion, thus contributing to neurodegeneration. To
address this, we have assembled a multi-disciplinary team with a proven track record of collaboration, including
with ADSP and ADGP members, who bring expertise in vascular pathology in dementia, endothelial cell (EC)
signaling and EC functional testing, Alzheimer’s Disease genomics, single cell and nuclear transcriptomics,
bioinformatics, CRISPR-based gene editing for large scale screening and AD mouse models for in-depth
functional assessment in vivo. Notably, we will address differences in gene effects related to the important
biological variables, sex and metabolic disease. Men and women differ in their genetic risk for Alzheimer’s
Disease, with sex-specific polygenic risk scores providing better prediction of onset, progression, and pathology
than pooled-sex scores. Over 80% of individuals with Alzheimer’s Disease have co-morbid metabolic disease,
which exacerbates vascular pathology. We have identified the top 50 AD-risk SNPs and 600 AD-associated
genes, and these will be targeted for induced pluripotent stem cell (iPSC)-derived endothelial cell (EC) screens
by prime editing and CRISPR-based gene inhibition and activation approaches respectively. iPSC-based
production of human ECs and mural cells in 2D and 3D models has been optimized and scaled to enable efficient
functional testing of the impact of gene changes, including on neuro-vascular interactions in cerebral organoids.
Discoveries made in these human cell systems will be validated by an in-depth investigation of gene expression
changes in individual ECs and mural cells across a large collection of Alzheimer’s Disease brain samples using
single nuclear sequencing. The EC translatome will also be obtained from mouse Alzheimer’s Disease models
that incorporate sex and metabolic disease. These diverse datasets will be harmonized and integrated in order
to map vascular phenotypes of AD-risk genes and identify critical molecular pathways that are targetable drivers
of AD cerebrovascular pathology. These data will add to the breadth of knowledge being gathered by other
groups to further elucidate underlying neuronal, glial, microglial, endothelial and mural cell-cell interactions that
contribute in a substantial way to the complex architecture of Alzheimer Disease pathology.
1

Public health relevance
PROJECT NARRATIVE Significant progress in identifying genes that accelerate or slow Alzheimer disease now leads to a critical question, how do these genes act to alter disease progression? We will focus our studies on the impact of these genes on brain vascular pathology which is present in almost all Alzheimer’s disease patients and has been shown to be an early driver of loss of brain function. Because hundreds of genes are potentially involved, we will use large-scale cutting-edge gene editing and screening methods for initial analysis. This will create a prioritized list of genes for focused functional studies in human stem cell models and mouse models. The goal is to identify early events leading to vascular pathology that can be targeted to combat Alzheimer’s disease.